Understanding and Targeting the Pathophysiology of Youth-onset Type2 Diabetes

Type 2 diabetes (T2D) in childhood has an aggressive etiology, with substantial short- and long-term
health complications and medical costs. There is an urgent need to: 1) identify children and adolescents at
highest risk; 2) identify modifiable contributing factors; 3) understand the underlying pathophysiology; and, 4)
determine how these factors vary across sex and race/ethnicity. A comprehensive and holistic understanding of
these issues is required to develop models that can identify individual factors and susceptible time windows for
T2D conversion and requires a nationwide effort and multidisciplinary consortium. We propose to serve as 1 of
the 15 Clinical Centers operating within the proposed NIDDK consortium that will recruit and track a national
cohort of children (estimate = 3,750) representing the diversity of the pediatric population at risk for T2D. Our
multidisciplinary team has extensive expertise in longitudinal studies of obesity and diabetes in children, including
an NIDDK-funded 15-year longitudinal study (R01 DK 59211; PI: Goran) that followed a cohort of 300 Latino
children at risk for T2D, resulting in almost 100 publications. From this and other prior studies, we have identified
the need for a larger and more diverse cohort, incorporation of environmental exposures, and inclusion of
comprehensive nutritional, metabolic, and social determinants. At our site, we will recruit 250 participants
with obesity and family history of T2D with bi-annual assessments. We will work with stakeholders and other
consortium sites to optimize recruitment and retention. We propose three complementary approaches to assess
the metabolic basis of T2D: insulin secretion, clearance, and β-cell function from an oral glucose tolerance test
with frequent sampling; hemoglobin A1c, and percent time in range from continuous glucose monitoring. We will
monitor metabolic and environmental factors by measuring: 1) total body fat, visceral and subcutaneous
abdominal adipose tissue, and liver and pancreatic fat by DEXA and MRI; 2) biochemical markers (free fatty
acids, sex steroids, lipids, inflammatory profiles, incretins, and liver enzymes); 3) lifestyle (diet, sleep, and
physical activity); 4) exposure to endocrine-disrupting chemicals and air pollution; 5) social determinants of
health. In addition, we propose collection of biological samples (eg DNA, stool, saliva) to create a biobank for
future investigation. We will work with the consortium to develop a unified protocol and harmonized outcome
measures. We hypothesize: 1) Children who develop T2D will have a greater pubertal decline in β-cell function,
and decreased glucose time-in-range, which will be associated with greater increase in overall adiposity and
liver fat, compared to children who do not develop T2D, and that these relationships will differ across sex and
ethnicity; and, 2) High dietary sugar, limited access to healthy foods, and higher exposure to perfluoroalkyl
substances and/or air pollutants will also be associated with risk of T2D. Through harnessing the power of this
consortium, we also propose development of a structured risk score analysis to characterize different endotypes,
exposures and risk factors that predict progression to T2D during pubertal development.

Public health relevance
Project Narrative The obesity epidemic has led to an increased risk for youth to develop type 2 diabetes, particularly during puberty and in minority populations. There is a need to comprehensively understand the underlying pathophysiology of T2D progression in youth to identify those at the highest risk for developing T2D as well as any modifiable exposures and determinants of T2D progression and how these factors differ regarding sex or race/ethnicity. With the power of this large clinical consortium, the development of a structured risk score analysis can be achieved to help identify youth at the greatest risk and optimize interventions during this critical developmental period designed for long-term prevention of type 2 diabetes.